Receptor usage and pathogenicity of feline lentiviruses

The overall aim of this project is to identify the cellular receptor(s) for the feline lentiviruses and to examine the role of the virus-receptor interaction in the pathogenesis of AIDS. The project will build upon our earlier work demonstrating that CXCR-4 is the major, if not sole, co-receptor for the feline immunodeficiency virus (FIV) lentivirus of the domestic cat. In the domestic cat, FIV infection induces an immunodeficiency syndrome similar to AIDS in HIV- infected humans. In the proposed studies, we will ask whether receptor usage determines pathogencity of feline lentiviruses in domestic vs. non-domestic cats as is postulated for receptor usage and pathogenicity in primate lentiviral systems. Several lines of evidence suggest that primary strains of FIV require the co-expression of another cell surface molecule (perhaps analogous to the HIV receptor CD4) in addition to CXCR-4 in order to infect all target cells. Aim 1 will determine whether FIV utilizes a primary receptor beside CXCR-4 for infection of feline cells. We will use retroviral pseudotypes to screen cDNA libraries for additional receptor(s) and/or co- receptors and the function of the molecule(s) will be characterised. Aim 2 will examine the link between receptor-usage and pathogenicity. We will ask whether receptor usage varies among feline lentivirus isolates, i.e.: (a) isolates characterized as pathogenic vs. non-pathogenic in experimental studies; (b) isolates obtained from asymptomatic vs. symptomatic naturally infected cats; and (c) isolates transmitted via different routes in experimental studies. Aim 3 will investigate whether non-domestic vs. domestic cat lentiviruses use different vs. common viral receptors. The lentiviruses of the non-domestic cats appear to be more ancient and more adapted to their host species than is FIV to the domestic cat. We will investigate whether receptor-usage is a determinant of host-adaptation. These studies will elucidate the cellular receptor(s) for the feline lentiviruses, determine whether changes in receptor usage relate to pathogenicity, and forecast the future of both FIV/domestic cat and HIV/human receptor-virus evolutionary outcomes.